Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories

Maintenance and Enhancement of ISO/IEC 17025 Accreditation for State Food Testing Laboratories (U18) Project Summary The Washington State Department of Agriculture (WSDA) Food Safety and Consumer Services (FS-CS) Laboratory seeks funding from the U.S. Food and Drug Administration (FDA) under FRA-FD-17-010. Funding level requested is $350,000 over two years. The title of our proposal is: Maintenance and Enhancement of ISO/IEC 17025 Accreditation of the WSDA FS-CS Laboratory’s Quality Management System After several years of intense work by the WSDA Food Safety and Consumer Services (FS-CS) Laboratory to prepare for and implement a Quality Management System, the WSDA Microbiology Laboratory became ISO/IEC 17025:2005 accredited on December 22, 2011, and has successfully maintained the accreditation since then. The WSDA FS-CS Laboratory goals for this two-year project are: ? maintain and improve the ISO/IEC 17025:2005 accreditation ? strengthen the successful collaboration between FS-CS Laboratory and Food Safety program at WSDA; increase the number of state samples collected and analyzed for surveillance purposes. ? provide mentoring and technical support to other states food labs to obtain/maintain their accreditation The WSDA FS-CS Laboratory meets all eligibility requirements for this funding opportunity: ? WSDA FS-CS Laboratory is the primary regulatory food testing laboratory in Washington State and has adequate resources to achieve the project objectives ? WSDA FS-CS Laboratory is one of the awardees of the current ISO/IEC 17025:2005 Accreditation for Food Testing Laboratories cooperative agreement funded by the FDA Office of Partnerships ? WSDA FS-CS Laboratory has obtained ISO 17025:2005 accreditation from 2011 and seeks to maintain and improve the accreditation ? WSDA FS-CS Laboratory is a member of the Food Emergency Response Network and experienced in analyzing FDA regulated products the number of methods under scope of accreditation to aide in the analysis of those products ? WSDA FS-CS Laboratory sends food testing information and results electronically to eLEXNET In addition, the WSDA Food Safety and Consumer Services Laboratory is: ? Currently under contract with FDA to conduct food safety inspections ? Enrolled in the MFRPS WSDA FS-CS Laboratory is eager to partner with FDA, Washington State Food Safety Program, and other food testing laboratories across the nation, to protect the public’s health from food borne illnesses. 1 | Page FRA-FD-17-010: ISO/IEC 17025:2005 Accreditation for State Food Testing Laboratories

Public health relevance
Maintenance and Enhancement of ISO/IEC 17025 Accreditation RFA-FD-17-010 Project Narrative The Washington State Department of Agriculture (WSDA) Food Safety and Consumer Services (FS-CS) Laboratory has a history of demonstrated success as a FDA-ISO MCAP awardee Laboratory since 2012. As an MCAP member, WSDA FS-CS Laboratory actively participates in all activities associated with the Cooperative Agreement: maintain and improve the ISO accreditation, add more testing methods under the ISO scope, proficiency sample testing, training seminars, ISO-MFRPS conferences, teleconferences, group testing assignments as well as additional numbers of state samples collected and analyzed for the regulatory purposes annually. As an ISO17025:2005 accredited laboratory, we have a quality management system in place with dedicated quality assurance staff, a safety officer and procedures in place to assure good laboratory practices. We have laboratory facilities to assure the proper environment for advanced instrumentation in addition to secure sample custody and laboratory space. As a current FDA ISO grant awardee, the WSDA FS-CS Laboratory is applying for the cooperative agreement titled: Maintenance and Enhancement of ISO/IEC 17025 Accreditation for State Food Testing Laboratories (U18), announcement RFA- FD-17-010, with anticipation of funding for 2017-2019. The WSDA FS-CS Laboratory is willing and able to participate in the following project areas: 1. Ensuring microbiological and chemical food analyses performed on behalf of the State manufactured food regulatory programs are conducted within the scope of an ISO/IEC 17025 accredited laboratory. The WSDA FS-CS Laboratory shall participate in Washington Food Safety program/Manufactured Food Regulatory Standard Program (MFRPS) sample collection and analysis for surveillance purposes, food emergency outbreak testing and ensure large-scale food emergency event surge capacity by using various standardized cultural and biochemical analytical methods for the detection and identification of pathogens in food. 2. Strengthening the collaboration between the laboratories and State manufactured food regulatory programs and increasing the number of State samples collected and analyzed for surveillance purposes annually Our laboratory has maintained very solid and fruitful collaboration with the state Food Safety/MFRPS Program. The number of State samples (FDA regulated products) collected and analyzed will be increased over the grant two-year period. 3. Maintaining and improving the ISO 17025:2005 accreditation, and providing technical support to other States’ food laboratories in their ISO accreditation efforts ISO 17025:2005 accreditation was granted to the WSDA FS-CS Laboratory on December 22, 2011 under Certificate #3245.01 Biological, and we have successfully maintained the accreditation since then. More analytical methods utilized by our laboratory will be added under ISO scope during this grant cycle. Laboratory data generated related to food safety will be continuously shared through eLEXNET with FDA. Ideally, an electronic data exchange will also be maintained between the laboratory information management system (LIMS) and eLEXNET In conclusion, the WSDA FS-CS Laboratory wishes to continue as a FDA-funded ISO-MCAP Laboratory. We have met all program requirements and will strive to meet these requirements in the future. Our Laboratory and Department has gained immensely from participating in the first grant cycles of MCAP funding, and we look forward to continued participation and the associated challenges and rewards.